Deciphering the role of noncoding variation in the pathogenesis of multiple sclerosis

Project Summary
Multiple sclerosis (MS) is a chronic, inflammatory condition of the brain and spinal cord mediated largely by
pathogenic T cell responses to myelin antigens, resulting in demyelination of the central nervous system
(CNS). Myelin-reactive T cells are also crucial for induction of the experimental autoimmune encephalomyelitis
(EAE) mouse model of MS. Studies of MS and EAE implicate CD4 T helper (Th) cells in disease pathogenesis,
including pro-inflammatory Th17 and Th1 cells. In this regard, the disease-promoting ability of these T cell
subsets stems from both their capacity to target and infiltrate the CNS and their pro-inflammatory effector
function. An interplay between genetic and environmental factors is implicated in the pathogenesis of MS.
However, despite a wealth of genome wide association data (GWAS) data revealing a strong genetic
contribution to MS, it has been challenging to identify the bona fide disease-promoting gene target(s) of many
risk-associated variants, and the cellular compartment in which they contribute to dysregulation. In preliminary
work, we have applied global genomics approaches to map MS-associated noncoding risk variants to their
long-range target gene by physically capturing enhancer-promoter interactions. These MS-implicated genes
were further prioritized based on dysregulated expression signatures in pathogenic Th17 cells derived from MS
patients. Using this approach, we have identified putative regulatory MS variants and gene targets that control
CD4 T cell function in MS that are the basis of this application. We hypothesize that identifying noncoding
variants that alter the regulatory function of cis elements controlling proinflammatory T cells will provide novel
mechanistic insights into the underlying etiology governing the development of MS. Here, we propose an
integrative strategy to prioritize and validate causal genetic variants in MS pathogenesis. The goal of Aim 1 is
to determine the contribution of noncoding risk variants to CD4 T cell gene regulation. In particular, we will
employ a combination of high-throughput regulatory reporter assays and machine learning approaches to
identify SNPs with regulatory function in primary human CD4 T cells. In Aim 2, we will determine the
mechanism by which these regulatory variants contribute to altered T cell function and pathogenicity in MS.
Complementary CRISPR/Cas9-mediated genetic and epigenetic perturbations will define the enhancer context
of risk alleles and delineate bona fide regulatory gene targets of regulatory risk variants. Moving from genotype
to phenotype, we will define true causal variants that contribute to disease etiology in the context of an intact
immune system using genetic interventions that model conserved risk variants in mice. Together, the proposed
experiments will advance our understanding of the both the genetic and cellular mechanisms governing Th17
cell pathogenicity in MS and discover new loci with unknown functions in disease etiology.

Public health relevance
Relevance Statement Recent years have witnessed an explosion of information derived from genome wide association studies (GWAS) linking genetic variation with increased risk for diseases such as Multiple Sclerosis (MS). To date, little mechanistic insight has been gleaned from the majority of risk-associated variants, a challenge reflecting their primary localization to non-coding regulatory regions of the genome. The proposed work will capitalize on emerging genomics approaches to prioritize lineage-relevant MS risk variants, determine their mechanism of action in contributing to the pathogenesis of MS, and as such, provide new avenues for therapeutic interventions targeting MS.